MOR and CCR5 interactive signaling mediates opiate and HIV-driven synaptodendritic injury

Injection drug use increases the probability of contracting HIV, and opioids accelerate the progression of HIV-1
infection through immune suppression and direct CNS actions. Opioid receptors are widely expressed on
immune cells and glia, and opioids can modulate chemokine signaling. CCR5 plays a critical role in HIV
infection as a co-receptor for entry of CCR5-preferring strains. CCR5 levels in general, and in microglia/CNS
macrophages, have been correlated with severity of HIV neurologic disease. Individuals homozygous for the
CCR5Δ32 mutation resist infection, and the CCR5 antagonist maraviroc (MVC) is used clinically to inhibit HIV
entry. Results from the last funding period using non-infective paradigms reveal that CCR5 may also promote
HIV-related neuropathology apart from its role in enhancing HIV infection. For example, blockade of CCR5 with
MVC increases synaptic plasticity, reverses Tat-induced reductions in antinocicetion, tolerance, and morphine
dependence, and enhances survival of Tat-treated striatal neurons. CCR5 overactivation may be a pivotal
factor in the ability of opiates to amplify HIV neuropathogenesis, and heterologous interactions between MOR
and CCR5 likely underlie many CNS deficits in HAND. CCR5 and MOR interactions in the context of HIV are
likely fundamentally different among CNS regions due to distinct glial/neuronal distributions of CCR5 and
MOR, their ligands, and effector coupling. Critical to this proposal, MVC rescued Tat-induced deficits in a
spatial learning/memory task involving hippocampal function (Barnes maze), and hippocampal damage is
involved in learning/memory deficits in HAND patients, irrespective of cART. To explore the hypothesis that
aberrant CCR5-MOR interactions underlie HIV-induced hippocampal deficits, we will systematically interrogate
those interactions in the context of HIV/Tat and opiate exposure. In vivo and ex vivo studies in HIV-1 Tat
transgenic mice are complemented by in vitro studies using human neurons exposed to Tat, gp120, and HIV.
Three interrelated Aims test hypotheses in male and female mice. Aim 1 tests CCR5 impact on the dynamics
of HIV-1/Tat and MOR interactions in the hippocampus, using functional assessments of behavior (spatial and
non-spatial tasks) and neurophysiology (LTP and membrane properties in ex vivo slices). Aim 2 tests how
CCR5 activation or blockade (genetic, MVC) alters HIV-1/Tat and MOR interactions, using Tat, gp120, and HIV
in murine or human co-cultures of hippocampal neurons and glia. Neuron dysfunction (optical physiology),
[Ca2+]i homeostasis, synaptodendritic injury, and death, as well as underlying inflammation and signaling
pathways involved (bioplex/MSD multiplex) are explored. Aim 3 examines heterologous interactions between
MOR and CCR5, assessing receptor dynamics and activity by [3H]naloxone or [3H]maraviroc-stimulated
[35S]GTPγS autoradiography in hippocampal sections, and concentration-effect binding curves in membranes
from brain and cultured neurons/glia. TrkB and p75NTR roles in regulating outcomes tested pharmacologically;
protection by altering the proBDNF/mBDNF balance (tPA to increase proBDNF cleavage) assessed in all Aims.

Public health relevance
Opioid drug abuse appears to enhance CNS deficits that occur due to HIV-1 infection. In the past funding period we established that signals through µ-opioid and CCR5 receptors uniquely interact to promote inflammation, neuronal injury/death, and dysfunction in the striatum, and we developed new preliminary data that CCR5 blockade with maraviroc reverses performance deficits in a spatial memory test (Barnes maze) reflecting hippocampal function. Since cART-treated HIV patients still show hippocampal damage and have related cognitive deficits, and since the cellular expression of CCR5 and µ-opioid receptors and their ligands and signaling partners are unique to different brain regions, we will examine the unique, interactive role of MOR and CCR5 in orchestrating synergistic deficits in hippocampal pathology, neuronal dysfunction, and learning and memory, and assesses whether drug therapies that either inhibit CCR5 directly (maraviroc), or via the BDNF pathway (BDNF, tPA) will reverse detrimental effects of opiate drugs and HIV, using in vivo (behavior, structure), ex vivo (electrophysiology), and in vitro manipulations of neurons, glia, and brain aggregates (human primary and iPSC-derived).